Targeted Prevention of Postpartum-Related Breast Cancer (PRBC)

Postpartum-related breast cancers (PRBCs), herein defined as breast cancers (BCs) diagnosed within five years
after a birth, augur a poor prognosis. Although early age at first birth and multiparity lower risk of late onset BCs,
childbirth transiently increases risks of both estrogen receptor (ER)+ and ER- BCs for over two decades,
with peak risks at 5 years postpartum (parous vs. nulliparous: HR=1.80, 95%CI=1.63-1.99). Peak risks are even
higher among women with a family history of BC (parous vs. nulliparous: HR=3.53, 95%CI=2.91-4.29), and for
women whose first birth is at later ages (pinteraction=0.03). In preclinical models, post-partum involution (PPI), a
pro-inflammatory process which restores the breast to a non-lactating state after weaning, is linked to activation
of cyclooxygenase-2 (COX-2), which increases production of prostaglandins and results in an immune
suppressed, pro-carcinogenic “wound healing” microenvironment that drives BC progression; in these models,
treatment with non-steroidal anti-inflammatory agents (NSAIDs) inhibits PRBC development. Among women,
both postpartum normal breast tissues and BBD biopsies are characterized by significant inflammation. We and
others have reported significantly reduced risk of BC among NSAID users with benign breast disease (BBD),
suggesting a potential preventive benefit for women at risk of PRBC. We propose 3 aims to test the hypothesis
that dysregulated PPI increases risk of BBD and PRBC, and that inhibition of deleterious inflammation
following PPI can lower BC risk. In Aim 1, we will define and validate a PPI-specific immune signature
score to distinguish normal breast tissues of young nulliparous from parous women (obtained within 5 years of
a birth, matched by age) using 240 samples donated to the Komen Tissue Bank (KTB). We will also measure
eicosanoids, including prostaglandin E2, in frozen tissues from a subset (n=100) of these women. We will define
factors related to PPI immune signature score, hypothesizing that higher scores may indicate increased PRBC
risk. In Aim 2, we will refine and independently test whether a PRBC immune signature score based on 8
previously defined markers with a combined AUC=0.76 predicts risk in previously untested BBD biopsies (75
cases and 75 matched controls). We will compare PRBC immune signature scores in 707 BCs from women
aged 40 years or less by parity status, molecular subtype, and adjusted for potential confounders. In Aim 3, we
will conduct a window of opportunity clinical trial to test if a 6-week course of aspirin 81 mg per day can
reduce the deleterious inflammation associated with PRBC risk (i.e., PRBC immune score) and favorably alter
other BC risk markers in breast tissues, blood and urine. This significant and innovative proposal seeks to
define a unifying mechanism of pathogenesis for PRBC, which will provide the basis for developing a
short-term, well-tolerated prevention strategy using immune-targeting and/or anti-inflammatory agents
to prevent BC.

Public health relevance
PROJECT NARRATIVE This proposal would substantially expand our understanding of postpartum-related breast cancers (PRBCs) by: 1) defining proliferative and immune effects associated with pregnancy and healthy postpartum involution (PPI) after weaning; 2) assessing how breast cancer risk factors affect the intensity of inflammation associated with PPI, thereby identifying potential candidates for prevention; 3) defining an immune biomarker panel (i.e., PRBC Immune Score) that distinguishes inflammation associated with development of PRBCs from healthy PPI and 4) testing whether aspirin can reduce inflammatory changes in the breast linked to development of PRBCs (i.e., lower PRBC Immune Score). Further, by assessing the correlation of epidemiologic risk factors and inflammatory markers in blood and urine with changes in inflammation in breast tissues associated with a trial of aspirin, we aim to identify characteristics of women who may respond favorably to an anti-inflammatory PRBC preventive intervention. Thus, the knowledge gained from the three synergistic aims proposed in this application may help identify women at increased risk of PRBCs and identify candidates for short-term, well- tolerated preventive interventions with anti-inflammatory or immune agents.